Mass Spectrometric Tissue Imaging of Sugars, Glycans, and Glycoconjugates

PROJECT SUMMARY/ABSTRACT
The glycome describes the complete repertoire of cell carbohydrates that are either free or covalently linked to
lipid or protein molecules, having the span of biological roles from those that are subtle to those that are crucial
for an organism's development, function, or survival. Because those molecules are not encoded directly in the
genome, one cannot accurately predict the precise structures of glycans elaborated by a given cell type.
Furthermore, small changes in environmental cues can cause dramatic changes in glycans produced by a given
cell, which can often lead to pathology, and as such, developing capabilities for identifying those changes at the
cell-specific level is necessary. Historically, nuclear magnetic resonance (NMR) and mass spectrometry (MS)
have been used for glycome structural elucidation, but those techniques have limited capability to capture
chemical differences at the spatial level, while lectins and other glycan-labeling imaging approaches provide only
limited information on carbohydrates structures. Over the last decade, mass spectrometry imaging (MSI) evolved
as a powerful tool to link chemical structures with tissue localization, and it has been successfully used to reveal
differences in metabolites, lipids, and xenobiotics across numerous human tissues, cell types, and cell states.
However, MSI still hasn’t shown its full potential in glycome imaging due to carbohydrates' poor ionizability,
complex chemistry, and ambiguous molecular annotation. I have successfully solved some of those issues
throughout my career, enabling a better understanding of the glycome-phenotype relationship. Herein, I propose
to develop and advance MSI tools that will enable more accurate and comprehensive chemical characterization
of the glycome at tissue functional unit and cellular resolutions. I will develop various workflows, modify and
optimize existing MSI approaches, and, in combination with auxiliary tools, map soluble sugars, glycolipids,
proteoglycans, polysaccharides, and glycoproteins from the human tissues. More specifically, in combination
with high-resolving mass spectrometers, I will utilize various ionization and post-ionization sources, orthogonal
analyses, on-tissue chemical derivatization, in-tissue digestion, and glycan enrichment strategies to overcome
current limitations in glycome imaging. Successful completion of this research will create a robust, high-
throughput capability for glycome imaging that will enable an understanding of how, at the cell-specific level,
glycome processing and glycome redistribution mediate physiological and pathological processes, thus
addressing a critical gap in the Glycosciences area of the Biochemistry and Bio-related Chemistry Branch of
NIGMS.

Public health relevance
Project Narrative The goal of this project is to establish mass spectrometry imaging capability to enable the more accurate and comprehensive characterization of glycome (the entire carbohydrate repertoire) at near single-cell resolution. This capability will incorporate a series of innovative advancements to mass spectrometry imaging, ion mobility, ion activation, on-tissue chemical derivatization and enzymatic digestion, glycan enrichment, and micro- processing of small amounts of material to overcome current limitations in glycome spatial analysis. The ability to map the dynamic and heterogeneity of glycome to tissue functional units and cells will greatly assist in identifying carbohydrate structures underpinning cellular function in the tissue context.